Untargeted Chemical Analysis of Feminine Hygiene Products

This project is designed to understand what chemicals females are exposed to in every day consumer products, specifically feminine hygiene products. Approximately, five different brands from each of the following 7 product categories (35 products): tampons, pads, feminine wipes, douches, feminine deodorant, feminine wash, feminine anti-itch cream will be evaluated. Additional samples or analyses may be conducted after full analyses. Analysis of daily diary information collected from the “NIEHS-EPA Collaborative Project to Improve Characterization of Personal Care Product and Home Exposures” will inform product brand selection. Testing brands reported in the daily diaries may help facilitate interpretation of the untargeted chemical analysis work in biological samples proposed above. This analysis will also be used to inform EPA exposure prediction models. Together, this information will provide chemical exposure information for consumer products women are exposed to and further provide actual chemical concentrations in products which will help to improve exposure prediction models.